Data and Statistical Core

DATA AND STATISTICAL CORE
PROJECT SUMMARY
Mouse studies sponsored by The Jackson Laboratory Nathan Shock Center (JAX NSC) produce an enormous
amount of data, including phenotypic, genetic, epigenetic, expression profiling and microbiome profiling data.
Our focus on genetic diversity using Collaborative Cross (CC) inbred and Diversity Outbred (DO) mice requires
the analysis of hundreds of mice. With new phenotyping technologies constantly being developed, the scope of
data collection and analysis continues to grow. Thus, a well-functioning and efficient data management and
statistical analysis operation is necessary. The overall goal of the JAX NSC Data and Statistical Core is to provide
support for the management, quality control, analysis, and dissemination of data for JAX NSC projects. The
Specific Aims of the Data and Statistical Core are to: Aim 1. Develop and maintain the data management,
quality control, and analysis infrastructure needed to support JAX NSC projects. We will continue to
develop this system to implement automated data collection and quality control procedures for our growing
portfolio of pilot projects and collaborations. Aim 2. Disseminate JAX NSC data and analytical tools to
provide greater access to these and other data resources related to mouse models in aging research.
This aim will support development of new data types and web-based interactive tools. We will mine public
repositories for aging-related transcriptional profiling data from mouse studies to update and integrate with JAX
NSC data. Aim 3. Provide study design and statistical analysis support for the aging research community.
The Core will engage in collaborative research with members of the aging research community to support the
broader adoption of genetic diversity in aging studies that use mouse models. This outreach activity will be
managed and tracked in parallel with projects in the other JAX NSC Cores but with an emphasis on working with
collaborators who have or who plan to generate their own primary experimental data. The Data and Statistical
Core is significant because it will provide efficient, comprehensive and cutting-edge management, analysis, and
dissemination of data generated from aging mouse studies focused on understanding the genetic factors that
underlie lifespan and healthspan. Improved data management and quality control methods, greater emphasis
on active outreach to promote use of JAX NSC data, and deeper engagement with collaborative projects, will
accelerate the pace of aging research, enhance the impact of the Core on the geroscience research community
and increase the visibility of the JAX NSC data and other resources.